Robust Capture Arrays for Cancer Proteomics Research

[unreadable] DESCRIPTION (provided by applicant): Study of protein expression and protein-protein interaction is of central importance to understanding oncogenesis and cancer progression. Robust protein capture arrays will greatly facilitate cancer proteomics research. There is an acute need in designing novel types of affinity binders that are easy to express, smaller in size, highly stable, and extremely economical to screen and manufacture. This proposal describes a novel engineered protein scaffold for rapidly generating antibody-like molecules by using molecular selection processes. If the proposed project progresses to phase II/III, it will offer great commercialization opportunity in areas of proteomics research, molecular diagnostics and assay development for drug screening. [unreadable] [unreadable] PUBLIC HEALTH RELEVANCE: This project is related to development of a type of protein capture array for cancer research and diagnostics. The focus of the proposed work is to create a novel class of affinity reagents to accelerate deciphering gene function in the post-genomic era, with broad implications in improving human health. [unreadable] [unreadable] [unreadable]